EFFECTS OF DILTIAZEM IN THE TREATMENT OF SUBCUTANEOUS CALCINOSIS DERMATOMYOSITIS

The specific aim is to study the effect of the calcium channel blocker diltiazem in dystrophic calcinosis in childhood dermatomyositis.